A COMPARATIVE STUDY OF COSTS FOR DENTAL SERVICES IN THE U S AND NORWAY

This work explores both the similarities and differences between the United States and Norway in terms of the economies of the two countries and their dental care delivery systems.